Alcohol metabolism potentiates HIV-induced lung and liver multimorbidity via inter-organ crosstalk

Human immunodeficiency virus (HIV) / acquired immune deficiency syndrome (AIDS) remains one of the most
critical public health problems in the 21st century, with more than 39 million global infections. Antiretroviral
therapy (ART) significantly suppresses viremia, leading to a decline in AIDS-related mortality. Conversely,
there are emerging concerns of multimorbidity (i.e., co-occurrence of ≥2 chronic diseases) despite ARTinduced
longevity. Multimorbidity significantly impacts the health quality of people living with HIV (PLWH) and
poses a substantial financial burden on the healthcare system. While HIV drives multimorbidity, alcohol,
consumed by more than 50% of PLWH, promotes HIV-associated multimorbidity. Alcohol mediates
multimorbidity by promoting organ-organ crosstalk via extracellular vesicles (EVs) and inflammatory mediators.
The direct effects of HIV and alcohol on the lungs and the liver have been demonstrated; however, there is a
gap in knowledge about whether HIV- and alcohol-induced lung and liver injuries are regulated by EVmediated
crosstalk. The objectives of the studies outlined in this proposal are to investigate the triggering
effects of alcohol metabolism and HIV on the secretion of lung-derived EVs and the role of these EVs in
amplifying the release of liver cytokines into circulation to induce lung injury. To achieve these objectives,
during the K99 phase of this award, the PI will determine how alcohol enhances EV release in HIV-infected
alveolar macrophages (AMs) (Aim 1). Then, the roles of EVs secreted by alcohol and HIV-stressed AMs in the
depletion of alveolar epithelial cells and barrier dysfunction will be examined (Aim 2). During the R00 phase,
the PI will examine the contribution of EVs to lung-liver crosstalk driven by HIV infection and ethanol
consumption in vivo (Aim 3). Successful completion of these studies will identify molecular targets that will
make it possible to concurrently address both lung and liver multimorbidity among PLWH who misuse alcohol.
The support from this K99/R00 grant will provide the PI with an outstanding opportunity to expand and
consolidate his experimental and laboratory skills, collect critical preliminary data for subsequent grant
applications, present research findings at national meetings, and support his career goal of becoming an
independent investigator. Thus, this K99/R00 application presents an excellent opportunity to advance the
career of the PI by developing an independent research program with a focus on HIV- and alcohol-induced
inter-organ crosstalk during the R00 phase.

Public health relevance
PROJECT NARRATIVE Heavy alcohol use is associated with increased respiratory symptom burden in people living with HIV (PLWH), and alcohol increases the risk of sepsis and multimorbidity of the lungs and liver in PLWH. In this proposal, the PI will determine if alcohol and HIV induce apoptosis of lung immune cells, alveolar macrophages, and promote the release of extracellular vesicles which impair alveolar epithelial barrier function, causing lung leak, and potentiate liver injury; thereby exacerbating lung injury. The findings from the study will not only identify potential treatment strategies for PLWH with AUD but also raise awareness of the impact of alcohol misuse on HIV-induced multi-organ damage.